Validation and Identification of Genetic Variants in Peyronie's and Dupuytren's Disease that Predispose to Fibrosis and Inflammation

PROJECT SUMMARY / ABSTRACT
Superficial fibrotic diatheses affect up to 7-12% of the United States male population. These conditions include
Peyronie’s Disease (PD), which results in penile plaques and resulting curvature during erection, and
Dupuytren’s Disease (DD), resulting in nodules of the palmar fasciae and hand contracture. While considered
benign, these conditions cause physical impairment and negatively affect relationships, and have been linked to
significant psychological ramifications, including clinical depression. These superficial fibrotic diatheses can be
heritable, co-existing in 15-22% of patients, and may be linked to other genetic conditions, including malignancy.
Current treatments are incompletely effective, in part due to a limited understanding of the pathogenesis of, and
molecular and genetic contributions to, these diatheses.
Previous work by our group identified microdeletions in several genes implicated in inflammation that may
predispose to fibrotic plaque formation. The proposed work will seek to understand the roles of these candidate
genes, NELL1, CTDSPL, and ZNF277 in fibrosis and inflammation contributing to PD and DD using in vitro
assays and animal models. Specifically, this basic research investigation addresses the hypothesis that NELL1,
CTDSPL, and ZNF277 modulate signaling pathways involved in fibrosis and inflammation, and that alterations
in gene dosage or function can predispose to aberrant collagen deposition and fibrotic plaque formation. The
proposed work will define the impact of alterations in expression and function of NELL1, CTDSPL, and ZNF277
on the TGF-β pathway in fibroblasts derived from patients with PD and/or DD and from genetically altered mice,
as well as the impact on collagen deposition and fibrosis in vitro. We will also investigate the impact of deficiency
of these genes on systemic and penile fibrosis using genetically altered mouse models to more definitively
establish causality in the setting of genetic defects in these genes.
The second aim of our project will utilize the Utah Population Database (UPDB) to identify familial cases of PD
and DD and to determine associated comorbid conditions in these patients. An exploratory analysis to identify
causal genetic alterations in familial PD and DD cases, with a focus on genes involved in the TGF-β pathway,
will also be performed.
The data obtained from this work will provide a detailed understanding of how NELL1, CTDSPL, and ZNF277
influence the formation of aberrant fibrosis on a molecular level and will also result in an understanding of the
spectrum of genetically influenced conditions that are associated with PD and DD. Together, these data will
provide the groundwork for improving patient diagnosis, risk stratification, and targeted treatment.

Public health relevance
PROJECT NARRATIVE This project aims to determine the influence of previously identified gene defects on the development of superficial fibrosing disorders, including Peyronie’s and Dupuytren’s diseases, as well as to identify associated and comorbid conditions in familial cases of these diseases. A deeper understanding of the genetic factors that underpin these conditions will facilitate patient risk stratification and permit development of targeted, effective therapies for these conditions.